Understanding the Barriers to Physical Activity in Pediatric Pulmonary Hypertension in Order to Design Effective Home-based Exercise Programs

PROJECT SUMMARY/ABSTRACT
This K23 Mentored Patient-Oriented Research Career Development Award will prepare Dr. Catherine
Avitabile, a pediatric cardiologist and pulmonary hypertension specialist, for an independent research career
focused on exercise interventions to improve lean mass, functional capacity, and quality of life in children with
pulmonary hypertension and other heart diseases. Dr. Avitabile’s application is strengthened by her clinical
expertise and her prior research demonstrating lean mass (skeletal muscle) deficits in association with worse
exercise performance in cardiac patients. Under the mentorship of Drs. Babette Zemel and Stephen Paridon,
Dr. Avitabile will pursue a comprehensive career development plan with training in exercise physiology and
interventions, body composition assessment, wearable activity monitoring, and qualitative methods.
The growing population of pulmonary hypertension survivors report low quality of life and exercise
intolerance. Children with pulmonary hypertension engage in less physical activity compared to peers, which is
a concern since adult data support exercise as a non-pharmacologic therapy. Exercise training safely improves
exercise performance and quality of life in adults with pulmonary hypertension and in one small pediatric study,
but therapeutic exercise has not been widely adopted in pediatric pulmonary hypertension. While
cardiopulmonary status may limit exercise participation, other barriers to participation have not been explored. It
is also unclear how exercise interventions have a clinical effect as they may have multiple targets. Skeletal
muscle abnormalities are associated with worse exercise performance in adults with pulmonary hypertension
and could be modifiable through exercise interventions. Dr. Avitabile has identified skeletal muscle abnormalities
in children with pulmonary hypertension, and these are the focus of her research interests.
Exercise interventions that slow symptom progression would improve wellbeing for pediatric pulmonary
hypertension survivors and their families. Dr. Avitabile’s proposed research will increase understanding of the
health consequences of physical inactivity and identify barriers to exercise in pediatric pulmonary hypertension
patients in order to design effective exercise interventions. Aim 1 explores the association between physical
inactivity and muscle deficits. Aim 2 employs qualitative interviews to identify barriers to physical activity in order
to strengthen intervention design. Aim 3 tests the feasibility and preliminary estimates of efficacy of a home
exercise intervention to increase physical activity and improve functional status. The intervention is enriched by
data from wearable activity monitors, closely aligned with the priorities of the 2016-2020 NIH-Wide Strategic
Plan. This K23 award will support Dr. Avitabile’s pathway to independence as a pediatric cardiologist/pulmonary
hypertension expert skilled in exercise physiology and interventions, body composition assessment, and mobile
health technologies. These skills will support her future R01 proposals that will use exercise to improve survivor
wellbeing and will provide a model for exercise interventions in other cardiac patient groups.

Public health relevance
PROJECT NARRATIVE Pediatric pulmonary hypertension is a life-threatening disease of the lung vasculature that can result in right heart failure and death, but the population of survivors is increasing due to pharmacologic advances. Survivors report low quality of life related to symptoms of exercise intolerance, and adult literature supports exercise training as an adjunct to pharmacologic therapy. The proposed training program and research studies aim to increase understanding of barriers to exercise in pediatric pulmonary hypertension survivors in order to pilot a home-based exercise program which may lead to new therapeutic approaches and improved quality of life.